Metabolic basis for the persistence of dormant Toxoplasma gondii infection

Dormant Toxoplasma gondii [Toxoplasma] infection is characterized by dormant bradyzoite stage parasites
that reside within thick-walled cysts that develop inside neurons in the central nervous system. Cysts provide
a structural and physiological habitat that sustains the viability of dormant bradyzoite stage parasites. While
many targets and therapeutics have been identified to effectively treat the active Toxoplasma infection that is
defined by rapidly replicating tachyzoite stage parasites, therapeutic strategies or drugs that eliminate
dormant bradyzoites and their cysts have not been identified. The identification of potential targets to perturb
or eliminate dormancy has proven challenging for many microbes, including Toxoplasma, because microbial
dormancy is characterized by a reduced metabolic state that sustains viability but not replication. Several
lines of evidence support the hypothesis that dormant bradyzoites have markedly reduced mitochondrial
functions and rely more heavily on acquiring host glucose not just for energy production but also to meet an
increased demand for glucose to build bradyzoite-stage amylopectin and cyst wall glycan biomass. Consistent
with this hypothesis, our data has shown that blocking the utilization of host glucose markedly reduced the
development as well as the persistence of dormant stage bradyzoites. Here, we propose to define the
metabolic basis that underpins the ability of glucose starvation to prevent the development and persistence
of dormant bradyzoites. Targeting mitochondrial functions such as the electron transport chain has been
shown to have a partial ability to perturb but not to eliminate dormancy. We hypothesize that targeting glucose
or glucose + lactate utilization in combination with inhibition of mitochondrial function will accelerate the
demise of dormant bradyzoites and their cysts. The work in this proposal charts a way forward to identify a
metabolic basis to eliminate Toxoplasma dormancy.

Public health relevance
Currently, there is no drug or strategy that targets or eliminates dormant Toxoplasma gondii infection. This project will identify and validate a metabolic basis to eliminate the dormant stage of Toxoplasma gondii infection. The results obtained in this work will advance mechanistic understanding of dormancy, and will illuminate and test new strategies that can eliminate the dormant stage of infection.